Translaryngeal Vibration for Hyperfunctional Voice Disorders

PROJECT SUMMARY / ABSTRACT
High-quality research designs have demonstrated that voice therapy has a positive impact on hyperfunctional
voice disorders associated with muscle tension dysphonia (MTD). Among the options of behavioral voice
therapy for MTD, one of the most effective evidence-based approaches is flow phonation (a.k.a., stretch-and-
flow voice therapy). However, the phenomenon of post-treatment outcome measures remaining substantially
outside the range of normal is a ubiquitous finding in studies investigating this and other voice therapy
approaches. From both a cost burden and quality of life perspective, this phenomenon supports a need to
develop and refine voice therapy treatment approaches to promote better outcomes. Vibration is a physical
modality that has a historical use in the rehabilitation professions, but only recently has it been scientifically
studied as a modality for voice therapy when used by speech-language pathologists. When applied locally on
the perilaryngeal surface as a local translaryngeal vibration therapy (LTLV), early research has demonstrated
beneficial effects on voice physiology and clinical outcomes. Further high-quality clinical research studies are
needed to evaluate the efficacy of LTLV as a modality for voice disorders and to better understand the effects
of vibration and effective vibration dose on voice rehabilitation outcomes. The research proposed in this R15
has the potential to transform clinical practice of treatment for MTD, the most common voice disorder among
treatment-seeking populations. That potential is vested in the pursuit of three specific aims: (1) determine the
clinical efficacy of LTLV as a concurrent treatment using flow phonation voice therapy in patients with MTD,
and (2) determine the effect of treatment dose on clinical response associated with treatment outcomes. In
addition to the potential impact of this R15, the innovative of approach of using LTLV as a concurrent modality
with flow phonation combined with investigation of the most effective frequency parameter for clinical
application represents a pioneering approach to advance the field of clinical voice practice in speech-language
pathology.

Public health relevance
PROJECT NARRATIVE Contemporary treatments for hyperfunctional voice disorders such as muscle tension dysphonia (MTD) are effective but typically do not restore voice handicap or voice function to normal thresholds. Recent reports of vibration as a voice therapy modality have been published, but many questions remain about the efficacy of this tool. The current project addresses these problems through a blinded and randomized controlled trial to investigate the efficacy of local translaryngeal vibration for MTD and the dose-response relationship of this modality when compared to treatment without vibration.